Regulation of methionine metabolism in NASH by PPARgamma

Project Summary/Abstract
Non-alcoholic fatty liver disease (NAFLD) is the leading cause of chronic liver disease with a worldwide
prevalence of 25%, and without a FDA-approved pharmacological therapy. Thiazolidinediones (TZD) are the
agonists of peroxisome proliferator-activated receptor γ (PPARγ), and they are a potential therapy for NAFLD.
However, PPARγ is a nuclear receptor and well-known steatogenic factor expressed in hepatocytes that
contributes to the development of NAFLD by enhancing hepatic de novo lipogenesis (DNL) and fatty acid uptake.
We have assessed the role of hepatocyte PPARγ in the development of non-alcoholic steatohepatitis (NASH)
with adult-onset hepatocyte-specific Pparg knockout (Pparg∆Hep) mice in our K01 award. Specifically, we have
shown that hepatocyte PPARγ contributes to the onset of inflammation and fibrosis in mice with NASH,
suggesting a deleterious role of hepatocyte PPARγ on liver health. In addition, loss of hepatocyte PPARγ in
Pparg∆Hep mice enhances the anti-steatogenic, anti-inflammatory, and anti-fibrogenic actions of TZD in a model
of NASH. Interestingly, our RNAseq and metabolomics data indicated that hepatocyte PPARγ altered the
metabolism of methionine in the liver. Methionine plays a key protective role against NAFLD, and the effect of
PPARγ on its metabolism may explain why TZD-mediated activation of hepatocyte PPARγ reduced the
therapeutic effects of TZD in NASH. In this project, we hypothesize that hepatocyte PPARγ disrupts methionine
metabolism and promotes steatosis and liver injury by regulating gene expression and the ability to methylate
phosphatidylethanolamine and homocysteine. In order to test this hypothesis, we will identify the genes regulated
by PPARγ to control the use of methionine in NASH with chromatin immunoprecipitation sequencing in samples
of control and Pparg∆Hep mice treated with TZD (Aim 1). In addition, we will determine if PPARγ directly disrupts
the use of methionine in mouse primary hepatocytes of control and Pparg∆Hep mice with NASH using stable
isotopes (Aim 2). Overall, we will determine how hepatocyte PPARγ regulates directly methionine metabolism in
pathophysiological conditions. The results of this project will help us to develop novel approaches in our R01
proposals that will target specific mechanisms in preclinical models to improve NASH reversion.

Public health relevance
Project Narrative Non-alcoholic fatty liver disease affects to 25% of the population, and we do not have an effective pharmacological treatment yet. In order to identify novel molecular processes that promote this disease, and the subsequent target for new therapies, we are studying how PPARγ alters methionine metabolism in hepatocytes and promotes fatty liver disease. This information will be used to test novel therapies to prevent or reverse the development of fatty liver disease.